Effect of Mesophilic Anaerobic Biodigestion on Taenia solium Egg Survival, Viability, and Infectivity: An Approach for Future Implementation to Control Helminth Infections.

Project Summary:
Mesophilic anaerobic digestion (MAD) is a cost-effective technology used for household waste treatment
and renewable energy production in low- and middle-income countries. It involves the use of mesophilic
anaerobic digestion to process fecal waste, producing gas that can be used as cooking fuel. Additionally,
the biosolids and bioliquids produced as byproducts are nutrient-rich and can be used as soil and foliar
fertilizers, making MAD systems an attractive option for rural communities lacking sanitation and energy
infrastructure.
Despite their advantages, biodigesters can pose significant risks to human health. While previous studies
have reported adequate biosafety of the effluents, they have primarily focused on bacterial pathogens,
which are relatively easy to destroy. The highly pathogenic helminth species, such as Taenia solium, which
can lead to devastating infections of the central nervous system if the eggs are ingested, have largely been
ignored. The transmission of T. solium primarily occurs in rural agricultural regions, which are the same
regions where MAD systems could provide the greatest sanitation and economic benefits.
There is an urgent need to determine whether MAD systems destroy T. solium eggs and, if not, how to
optimize egg killing. To this end, experiments will be conducted to evaluate the survival and viability of eggs
with incremental duration of exposure to the MAD system. The infectiousness of eggs will be evaluated by
feeding them to pigs and conducting necropsies to detect the presence of parasite cysts in muscle tissue.
The main future goal is to modify the MAD systems to maximize egg killing and then evaluate these systems
in a community setting as an intervention to control helminths. If successful, this system will not only
improve hygiene in rural endemic areas but also positively impact the environment by reducing the use of
firewood as cooking fuel and decreasing indoor smoke that affects lung health, particularly among women.
Most of my research is related to evaluating the transmission dynamics of T. solium. In recent years, we
have learned about the behavior of this parasite in endemic areas such as the Northern and highland
regions of Peru and have developed transmission models that help us understand how this parasite can
return to previous levels after interventions that cannot be applied permanently. In general, my interest as
an early career researcher is to assess the impact of diseases both in silico and in the field and to focus
scarce resources on developing interventions with high public health impact.

Public health relevance
This research focuses on mesophilic anaerobic biodigestion (MAD) as a cost-effective and sustainable method to control Taenia solium infections. Additionally, the safe byproducts obtained from MAD systems could reduce harmful indoor wood-smoke from firewood, positively impacting respiratory health and promoting food security through the local production of fertilizers.